Single cell investigation of co-evolution in cancer cells and host cell immune microenvironment

Project Summary
How cancer cells co-evolve with their host microenvironment immune cells remains a critical
question in immunotherapy. The Wu lab focuses on the study of antigen-specific interactions and
their involvement in the cellular and molecular pathways underlying anti-tumor immunity. The
DFCI Translational Immunogenomics Laboratory (TIGL) was created to expand technology and
computational capabilities developed within the Wu Lab and provide a dedicated resource for
immunogenomic analysis across different cancer types. My current portfolio of projects is focused
on developing single cell/genomics techniques to understand the crosstalk between tumor cells
and immune cell populations within the tumor microenvironment and the selective pressure they
exert on each other. In particular, I have implemented: (i) rhTCRseq, a sensitive and robust
method to determine paired alpha and beta-TCR clonotypes in single cells as well as to perform
TCR repertoire analysis in bulk RNA samples that has revealed novel insights regarding the
impact of cancer vaccines on the generation of antigen-specific immunity, and is being widely
applied to the monitoring of other immunotherapy trials; (ii) Slide-TCR-seq for whole transcriptome
profiling and TCR clonotype identity detection in tissue sections that has been applied in different
human cancer types to provide insights on the spatial relationships between clonality, neighboring
cell types, and gene expression that drive T cell responses; (iii) ASAP-seq, a droplet-based 10x
Genomics method for transcriptome profiling, surface protein expression detection, and ATAC-
seq chromatin accessibility profiling (epigenome) in the same single cell; and (iv)nanoranger, a
flexible long-read sequencing workflow and analysis pipeline to integrate single cell transcriptome
profiling with genotypes. These diverse approaches have been and are being applied to several
NCI-funded projects in the Wu Lab. New initiatives focus on the further development and
implementation of novel single cell genomics technologies and their applications.

Public health relevance
Project Narrative Although new advances in the field of cancer immunology and genomics have transformed the way people are thinking about the importance of immunotherapy in cancer treatment, remaining questions of current immunotherapy are how the cancer cells and microenviroment immune cells evolve during therapy and how to increase the cancer patient response rate. Here, we propose to use novel single cell/genomics technologies to understand both the changes in cellular circuitry underlying malignancy initiation, progression, and transformation, and the co- evolving changes in the tumor microenvironment. These aims will be pursued in the context of existing NCI-funded research programs in the Translational Immunogenomics Laboratory directed by Dr. Catherine Wu at Dana-Farber Cancer Institute.